Mechanisms of mitochondrial mutation rate variation across eukaryotes

PROJECT SUMMARY
This administrative supplement will be used to replace a centrifuge that is essential to the project funded by the
parent award on mechanisms of mitochondrial mutation rate variation. The project relies on high-purity
isolation of mitochondria and chloroplasts from large quantities of tissue, using high-speed gradient
centrifugation. The NIH-funded equipment that was intended to be used for this project experienced
unforeseen damages that rendered it inoperable, and the requested replacement will be used to complete
project goals over the 4+ years remaining on the parent award.

Public health relevance
PROJECT NARRATIVE This administrative supplement will be used to replace a centrifuge that is essential to the project funded by the parent award on mechanisms of mitochondrial mutation rate variation. This equipment experienced unforeseen damages that rendered it inoperable.